Enabling the therapeutic delivery for spinal cord glioma by epidural light-guided modulation of blood-spinal-cord barrier

Abstract
Our proposal focuses on addressing the significant clinical challenges associated with intramedullary spinal cord
tumors (IMSTs). While IMST represent approximately 2% of all Central Nervous System (CNS) neoplasms, with
higher prevalence in the pediatric population, they are associated with high morbidity and pain and are invariably
fatal. Surgical options for diffusely invasive IMST (gliomas) are limited to partial debulking for palliation due to
the anatomical complexity and high risk of injury. Radiation, a standard of care for supraspinal gliomas must be
be used with caution and at lower doses due to the risk of radiation induced myelopathy. To add to the dearth
of therapeutic options, delivery of the great majority of chemotherapies and targeted drugs is limited by the
blood-spinal cord barrier (BSCB). Focused ultrasound (FUS), which is able to disrupt the BBB and is under
investigation for intracranial GBM, has limited utility for IMST due to the inability of FUS to penetrate through the
dense vertebral processes without risking thermal injury. There is also ample evidence that drugs delivered
through the intrathecal/CSF route, while effective of treating leptomeningeal disease, fails to gain access to the
brain/spinal cord parenchyma due to the brain-CSF barrier formed by the glial limitans. To address these
challenges, the overarching goal of our proposed work is to develop a novel and minimally invasive method to
enhance the spinal cord delivery of otherwise efficacious cancer therapy, test in de novo spinal cord glioma
model, and evaluate its application in large animal models (pigs). This is based on our recent work on optically
opening the blood-brain barrier using laser pulses and vasculature-targeted gold and iron oxide nanoparticles.
We hypothesize that the epidural light-based approach presents a unique advantage to temporarily open the
BSCB (epidural OptoBSCB) and enhancing drug delivery to spinal cord tumors. First, light can be delivered
minimally invasively into the spinal cord with epidural fiberoptic probes. Second, our preliminary data
demonstrate that OptoBSCB can be graded, is entirely reversible, and allows the entry of different therapeutics
into the spinal cord. Third, our findings indicate that calcium-mediated mechanobiological mechanisms underpin
the blood-brain barrier opening. We plan three aims to advance the therapeutic delivery for IMST. Aim 1 focuses
on characterizing the BSCB and OptoBSCB modulation in de novo IMST tumor model with a common BRAFV600E
mutation. Aim 2 centers on evaluating the therapeutic activity of Dabrafenib and Trametinib along with radiation
therapy and immune checkpoint inhibitor anti-PDL1 antibody, including synergy levels. Aim 3 will evaluate the
feasibility of optoBSCB in a large animal model using a custom designed epidural probe to minimally invasively
deliver light into the spinal cord. The outcome of our proposed studies will lead to new technology for BSCB
modulation and therapeutic delivery, including improved drug delivery and minimally invasive probes for epidural
light delivery.

Public health relevance
Narrative Intramedullary spinal cord tumors (IMSTs) have higher prevalence in the pediatric population, are associated with high morbidity and pain and invariably fatal, however, current surgical options for IMST are limited to partial debulking for palliation due to the anatomical complexity and high risk of injury. Our proposed work focuses on overcoming the blood-spinal cord barrier, with a novel technology OptoBSCB, which uses minimally invasive epidural fiberoptic probes and blood-vessel targeted nanoparticles, to enable therapeutic delivery into the spinal cord in both rodent and porcine models. Outcome of our proposed studies will lead to new technology for spinal cord therapeutic delivery including minimally invasive probes for epidural light delivery.